Scaling function-first antibody discovery leveraging memory B cells

ABSTRACT
Monoclonal antibody therapies represent a significant portion of blockbuster drugs, with their applications
expected to expand dramatically in the coming decade. However, current antibody discovery methodologies
often require trade-offs between performance and cost. Even state-of-the-art microfluidic approaches, despite
their high capital costs, are limited in their ability to sample the full antibody repertoire. There is a critical need
for advanced discovery tools that provide a comprehensive functional assessment of antibody performance
during screening while remaining accessible to a wide range of users.
Partillion Bioscience is addressing this need by developing workflows utilizing its specialized hydrogel
microparticle reagent ("Nanovials") that enable ultra high-throughput sorting of single B cells and antibody-
secreting cells (ASCs) based on secreted antibodies, using standard lab equipment and widely available flow
cytometers. This Phase II proposal aims to significantly enhance antibody discovery workflows by increasing
throughput by 10X. The proposed workflows will facilitate sophisticated functional antibody assays, such as
binding to cell-surface-expressed targets and receptor activation assays, leveraging both ASCs and primary B
cells. These innovations are expected to improve antibody discovery processes by expanding the antibody
repertoire and reducing the occurrence of non-functional sequences, ultimately leading to more efficient and
cost-effective therapeutic development.
Specific aims include: (i) developing on-nanovial functional screening assays for binding to cell-surface-
expressed targets and signaling pathway activation; (ii) discovering functional antibodies using a BCR-based
two-cell assay; and (iii) benchmarking the antibody sequences discovered through these approaches against
those recovered using standard hybridoma and BCR antigen baiting workflows. By making cutting-edge antibody
discovery capabilities more accessible and cost-effective, this work has the potential to accelerate the
development of therapeutic candidates and improve patient outcomes.

Public health relevance
NARRATIVE This research will contribute to the advancement of antibody discovery, a critical process in developing new therapies for various diseases. By increasing the efficiency and throughput of antibody screening, the project aims to enhance our ability to identify effective therapeutic candidates, ultimately leading to improved treatments that can enhance health, lengthen life, and reduce illness.